Validation of patient reported outcomes for female Veterans with upper limb amputation

Psychometrically sound methods of evaluating women's perspectives on upper limb prostheses are
needed to inform device design, clinical decision-making, and research. The field lacks valid and
responsive patient reported outcome measures (PROMS) that address prosthetic satisfaction, ability
to use a prosthesis in everyday life, socket fit and residual limb health. Widely used, existing
measures for amputees were developed for men, have never been examined in women, and/or not
validated for upper limb prosthesis users. Without validation, clinicians, regulators, payers and
researchers cannot select or utilize appropriate outcome metrics, and the needs and function of
female Veterans with upper limb amputation cannot be evaluated carefully. The overall objective of
this proposal is to develop and validate PROMS for persons with upper limb amputation, with
measurement precision enhanced using Rasch-based scoring adjusted for sex, if needed.
Specifically, we aim to: 1) Refine the Trinity Amputation and Prosthetic Experience Scale (TAPES)
Satisfaction subscale and the Orthotics Prosthetics Users Survey (OPUS) Client Satisfaction with
Device (CSD) scales to incorporate issues of concern to women, and then evaluate reliability, validity,
and gender-based scoring; 2) Develop and evaluate reliability, validity, and gender-based scoring of a
modified version of the OPUS Upper Extremity Functional Scale, the P-UEFS, which measures
perceived difficulty in activity performance when using an upper limb prosthesis; 3) Assess the
reliability, validity and gender based scoring of the Prosthetics Evaluation Questionnaire (PEQ) utility
and residual limb health subscales; and 4) Use the new metrics to compare prosthetic satisfaction,
self-reported activity performance, prosthetic utility and residual limb health of male and female
Veterans by amputation level, and device type. This mixed methods study will use a qualitative
approach for item generation, cognitive interviewing and pilot testing, and then a quantitative
approach for measure evaluation and comparisons by sex. The sample will consist of participants
who completed the baseline survey of our ongoing national studies of Veterans and service members
with upper limb amputation (funded by the DoD and VA) who have agreed to be contacted for future
activities. The cognitive interviewing sample will consist of 10 persons (5 men and 5 women); the pilot
testing sample will consist of 10 persons( a man and a woman) from each of the following sub-
categories: transradial amputation, transhumeral amputation, shoulder disarticulation/forequarter
amputation, bilateral amputation, non-prosthesis users. Fifty randomly selected participants will
participate in reliability testing, and 350 others will complete telephone interviews. Data from all 400
participants who complete telephone surveys will be used for calibration analyses. We will refine the
measures based on cognitive and pilot testing. We will then estimate test-retest reliability of the
refined measures, examine dimensionality and hierarchy of each measure and inspect items for
potential differential item functioning by sex. We will examine concurrent, divergent and known group
validity of each measure. Finally, we will use the measures to describe and compare outcomes of
men and women Veterans by amputation level producing generalizable data on prosthetic care in the
VA. This work will advance the field of outcome measurement for upper limb amputation, leading to
improved evaluation of prostheses and better care for women with major upper limb amputation.

Public health relevance
Women with upper limb amputation appear to be less satisfied with prostheses than men, and as a result may choose not to wear prostheses, or to wear devices that look good but offer minimal function. Understanding the needs of women Veterans with amputation is a priority for the Department of Veterans Affairs, given that there is very little research on this topic, and most of it comes from studies conducted outside of the United States and with civilians. Furthermore, the tools that are used to measure upper limb prosthesis satisfaction and function were developed for men with amputation and may not reflect the issues or concerns most important to women. The proposed study will modify existing tools to accurately measure how women with upper limb amputations feel about prostheses and how they use them in everyday activities. These tools will then be used in a national study of Veterans with upper limb amputation.